University of Texas Southwestern - Stimulating Access to Research in Residency (UT-StARR) Program

Project Abstract
Despite decades of research in the understanding and treatment of diseases of the heart and lung,
cardiovascular and pulmonary diseases remain the leading causes of hospitalization, disability, and death in the
U.S. Notably, growing numbers of patients with childhood-onset chronic illnesses, such as congenital heart
defects, cystic fibrosis, bronchopulmonary dysplasia, and hemophilia, are surviving into adulthood, making it
imperative to conduct research encompassing the lifespan. Against this background of critical research needs,
there is a strikingly growing shortage of M.D.-scientists, such that the proportion of M.D.s that remain primarily
in research careers has decreased by 3-fold in the last 3 decades, despite the climbing number of total physicians
in practice. The pipeline of M.D.-scientist development is also at risk: fewer medical students express interest in
a research career, and fewer graduates apply for NIH funding. Importantly, relative to the overall physician
workforce, women and minorities are disproportionately underrepresented in the proportion of M.D.-scientists.
These challenges require the implementation of innovative recruitment and training strategies to feed the M.D.-
scientist pipeline and ensure that women and minorities are well-represented. To help fill these critical gaps, we
will establish the University of Texas Southwestern (UTSW) - Stimulating Access to Research in
Residency (UT-StARR) training program to recruit and train a diverse group of Internal Medicine and Pediatrics
residents that will become the next generation of M.D.-scientists conducting laboratory-based, translational,
clinical, and population health research to detect, treat, and prognosticate diseases affecting the heart, lungs,
and blood of diverse populations throughout the lifespan. Our institution will provide an ideal environment with a
multidisciplinary cadre of funded research; robust didactic training program; and diverse patient population. We
hypothesize that the 3 axes of diversity at UTSW - M.D. trainees, mentors, and patient community - afford the
unique opportunity to address unmet needs in M.D. research training, personalized medicine, and population
health. The following Aims organize our approach: Aim 1. To provide broad-based comprehensive mentored
research training for a group of diverse Internal Medicine and Pediatric resident-investigators in the conception,
design, and implementation of laboratory-based, translational, clinical, and population research in diseases
affecting the heart, lungs and blood, encompassing detection, prevention, treatment, and outcomes to improve
the health of individuals and populations throughout the human lifespan; Aim 2. To provide the essential research
training and mentoring platform needed to build a strong foundation allowing successful transition of residents
to independent M.D.-scientists conducting biomedical research in the heart, lung, and blood fields; Aim 3. To
enhance the participation and persistence of M.D.s from underrepresented groups in research by implementation
and maintenance of institutional mentored residency training programs involving diverse residents, mentors, and
patients through evaluation and monitoring the progress of UT-StARR and other institutional training programs.

Public health relevance
Project Narrative There is a shortage of M.D.-scientists despite the growing need in research. We propose a research training program to train a diverse group of M.D. residents who will conduct laboratory-based, translational, clinical, and population research to detect, treat, and prognosticate diseases affecting the heart, lungs, and blood throughout the human lifespan.